Neural mechanisms of reactive aggression in adolescence: Altered reactivity during threat and reinforcement conditioning

PROJECT SUMMARY/ABSTRACT
Reactive aggression (RA) is a transdiagnostic indicator that permeates nearly all psychiatric disorders, and its
persistence into adolescence is linked to severe and intractable forms of psychopathology. Research suggests
this etiologically distinct form of aggression - defined as an impulsive, enraged attack triggered by perceived
threat (provocation or withdrawal of expected reward) - can be differentiated from other forms of aggression by
high levels of emotional reactivity. Yet, the underlying neural process by which heightened emotional reactivity
increases risk for RA remains unknown. While theoretical models link RA to heightened reactivity during two
fundamental learning processes - threat conditioning and reinforcement conditioning - threat- and reinforcement-
based dysfunction are typically examined in isolation and often outside the context of learning as predictors of
aggression, broadly defined. Further, aggression has typically been examined in disorder-specific samples (e.g.,
externalizing disorders), precluding the advancement of a transdiagnostic mechanistic model of RA. The current
proposal seeks to address these limitations by integrating neural and behavioral levels of analysis to examine
the independent and synergistic effects of threat and reinforcement conditioning on trajectories of RA in an at-
risk heterogenous sample of adolescents (n=105; 50% female). Specifically, this study will sample along a
continuum of risk for RA by recruiting youth (13-15 years) with low, moderate, and high emotional reactivity. The
central hypothesis of this proposal is that higher limbic activation, coupled with lower activation in prefrontal,
regulatory regions during fundamental learning processes will predict the persistence and exacerbation of RA
over time. Characterizing the neural underpinnings of fundamental learning processes that contribute to RA has
the potential to illuminate transdiagnostic neural processes critical to the development of mental illness. This
project will be the first in a larger program of research that will contribute to NIMH Strategic Priorities 2.1 by 1)
focusing on individual differences in neurobiological processes underlying RA as a transdiagnostic indicator of
risk and 2) improving our ability to detect youth at heightened risk for RA and related psychopathology. This
application details a comprehensive research and training plan that allows this candidate to address these
questions and develop the foundation necessary to become an independent investigator. Specifically, this
candidate will receive training in 1) a developmental neuroscience approach to the study of learning models
contributing to RA; 2) intensive training in neuroimaging acquisition and analytic methods among adolescent
populations; and 3) advanced longitudinal design and data analysis. This candidate has assembled a mentorship
team of senior investigators (Stepp, Luna) along with expert consultants, who possess stellar track records of
training junior scientists and supporting their development into highly successful independent investigators. This
expertise, combined with the resources afforded by the University of Pittsburgh, strongly position this candidate
to achieve her proposed training, research, and career goals.

Public health relevance
PROJECT NARRATIVE Reactive aggression (RA) is a transdiagnostic indicator that permeates nearly all psychiatric disorders in youth and its persistence during adolescence is linked to severe and intractable forms of psychopathology. Theoretical models link the development, persistence and exacerbation of RA to altered neural reactivity during two fundamental learning processes: threat and reinforcement conditioning; however, threat- and reinforcement- based dysfunction are typically examined in isolation and outside of the context of learning as predictors of aggression (broadly defined), precluding the advancement of a transdiagnostic mechanistic model of RA. The present study seeks to examine the independent and synergistic effects of neural reactivity during threat and reinforcement conditioning on trajectories of RA during adolescence, a critical period characterized by notable changes in the neural circuitry underlying conditioning and emerging trajectories of severe mental illness.